Role of Fbxw7-Mediated Proteasomal Degradation in Myofibers in Determining Muscle Stem Cell Pool Size

SUMMARY
The over-arching goal of this proposal is to delineate the signaling networks mediating the instructive role of the
myofiber on MuSC function. MuSC, also known as satellite cells, are the main source of skeletal muscle growth
and regeneration. In healthy adult tissues MuSC exist in a quiescent state, and upon stress or injury they are
activated to proliferate and generate large numbers of progenitors to efficiently repair damaged muscles. While
this process is efficient in healthy conditions, in several diseased conditions and during aging the numbers and
function of MuSC are impaired. Thus, there is a major need to understand the molecular networks regulating
their function, in order to identify novel tools or targets to enhance their tissue repair potential that can be utilized
in regenerative medicine approaches. Significant efforts in the recent years have defined a critical role of the
microenvironment in regulating MuSC function, by uncovering the integrated coordination of several tissue-
resident cells, such as inflammatory cells, fibroadipogenic progenitors and endothelial cells in regulating MuSC
tissue repair function. However, the role of the myofiber within the tissue microenvironment and in the MuSC
niche is still poorly defined. Our preliminary findings provide evidence that the E3 ubiquitin ligase Fbxw7 in
myofibers regulates MuSC pool size in a cell non-autonomous manner, suggesting that the myofiber plays a
major role in instructing stem cell function. We further identify PGC1alpha as a direct Fbxw7 target and the
upregulation of the PGC1alpha target irisin, a myokine that promotes MuSC differentiation. The identification of
signaling pathways that mediate the instructive role of the myofiber on MuSC pool size could identify strategies
to expand MuSC, thus allowing their use in regenerative medicine approaches. The objective of this application
is to take advantage of genetic models, unbiased proteomics and ubiquitinome profiling, gene expression
profiling and cellular biology techniques in order to delineate the signaling networks mediating the instructive role
of the myofiber on MuSC function. The central hypothesis to be tested is that the Fbxw7 in myofibers regulates
MuSC numbers in a cell non-autonomous manner by altering the MuSC niche. This integrated approach will
improve our understanding of myofiber/MuSC interactions, define the signaling networks mediating this process
and evaluate Fbxw7/PGC1α/Irisin as a critical axis to regulate MuSC pool size.

Public health relevance
PROJECT NARRATIVE Understanding how stem cell numbers are determined in tissues has fundamental relevance in order to uncover novel tools to promote tissue regeneration that can be utilized to ameliorate diseased conditions. Our work provides evidence that myofibers play a central role in determining skeletal muscle stem cell numbers in tissues in a cell nonautonomous manner. This proposal aims at defining the role of myofibers in determining muscle stem cell pool size, and identifying relevant cell-cell communications and secreted molecules involved in this fundamental process, in order to identify novel tools and targets to enhance stem cell-mediated tissue maintenance and repair.